Elucidating ligand-receptor interactions required for Plasmodium vivax blood-stage infection

Project Summary
Plasmodium vivax is the most widely distributed of all of the malaria parasites that cause human disease, and is
a source of considerable morbidity, and a major challenge for eradication, due to long-term persistence of
asymptomatic hypnozoites in the liver. The biology of P. vivax infections is poorly understood, in large part due
to the absence of a system for continuous in vitro culture. P. vivax strikingly invade only reticulocytes during
blood-stage infections, the youngest of red blood cells. The molecular mechanisms by which P. vivax invade
reticulocytes remain largely unknown. Previous research has focused on a single molecular interaction between
a P. vivax invasion ligand PvDBP and the host DARC receptor, but it is now known that invasion can occur
through pathways independent of DARC. We hypothesize that other members of the EBL and RBL families of
invasion ligands are likely to play a key role in binding to specific reticulocyte receptors to mediate successful
invasion. In this proposal, we build upon two major advances in our laboratory- the ability to generate gene
knockouts in red blood cells, and the ability to perform robust in vitro invasion assays with P. vivax. Using these
approaches, we have identified TfR1 as the receptor for the RBL protein PvRBP2b. We will now 1) conduct a
genetic knockout screen of red blood cell membrane proteins to comprehensively identify all of the reticulocyte
membrane proteins that are required for P. vivax invasion, and 2) identify key parasite ligands that bind to their
cognate red blood cell receptors, by interrogating candidate members of the EBL and RBL families in P. vivax,
as well as conducting an unbiased screen of P. vivax merozoite proteins. Together, these studies will serve to
dramatically increase our understanding of the molecular interactions between P. vivax and its host red blood
cell. In the long-term we hope that our studies will provide a functional understanding of the essential ligand-
receptor interactions required for P. vivax invasion, and inform vaccine development and the design of host-
targeted therapeutics.

Public health relevance
Project Narrative Despite the fact that P. vivax is a major causative agent of malaria, this parasite remains understudied leaving extensive gaps in our understanding of how it infects the youngest of red blood cells, known as reticulocytes. We will use genetic screens to identify receptors on the red blood cell surface and the parasite molecules used for cellular entry through these receptors. We anticipate revealing essential interactions between the host red blood cell and malaria parasite that can be targeted for the development of novel therapeutics and inform vaccine development.